Transcriptional co-regulators and macrophage gene expression

Project Summary
Tissue resident macrophages function as essential components of the innate immune system by serving as
sensors and responders to infection and injury. Functional and transcriptomic studies further indicate that
macrophages residing within different tissues are phenotypically distinct and exhibit correspondingly different
programs of gene expression that enable tissue-specific functions. In addition to their immune and homeostatic
functions, resident macrophages and infiltrating monocyte-derived cells also contribute to a diverse array of
metabolic and degenerative human diseases. Studies performed during the last funding cycle of this grant
demonstrated that different tissue environments play instructive roles in promoting distinct macrophage
phenotypes by driving the selection and function of cell specific enhancers. In parallel, studies supported by this
grant leveraged the effects of non-coding natural genetic variation provided by five different strains of mice to
investigate mechanisms controlling bone marrow-derived macrophage specific gene expression in vitro.
Evaluation of the effects of >50 million SNPs and InDels provided evidence for roles of ~100 TFs in shaping
lineage-determining factor binding and gene expression. Here, we propose to advance these genomic and
genetic approaches to identify mechanisms that specify the molecular identities of the resident and recruited
macrophages of the mouse and human liver in health and metabolic disease. Specific Aim 1 will test the
hypothesis that local DLL4, BMP/TGFb and desmosterol function in a sequential and combinatorial manner to
drive the selection and activation of Kupffer cell-specific enhancers by regulating RBPJ, SMADS and LXRs,
respectively. Specific Aim 2 will define the network of collaborative transcription factors required for establishing
the Kupffer cell enhancer landscape and quantify cell autonomous and non-cell autonomous effects of natural
genetic variation. Specific Aim 3 will investigate gene by environment interactions that regulate myeloid cell
phenotypes in NASH. Experimental strategies developed in Specific Aims 1 and 2 will be used to test the
hypothesis that myeloid diversity is the consequence of microenvironment-specific combinations of signals that
differentially reprogram the enhancer landscapes of resident Kupffer cells and recruited macrophages. These
studies are expected to lead to the identification of disease- and niche-specific signaling pathways that contribute
to pathological macrophage phenotypes in NASH. Specific Aim 4 will define the transcriptomes and epigenetic
landscapes of myeloid populations in the healthy human liver and across the spectrum of non-alcoholic fatty liver
disease. These studies will establish similarities and differences of human and mouse Kupffer cells, define
effects of genetic variation across individuals, and provide a map of regulatory landscapes of these cells that
can be used for interpretation of non-coding GWAS risk variants.

Public health relevance
PROJECT NARRATIVE Macrophages are essential for normal tissue homeostasis but also contribute to a diverse spectrum of metabolic diseases, including diabetes and non-alcoholic steatohepatitis. Studies proposed in this application will use a combination of genetic and genomic approaches to identify the signals that control homeostatic and pathogenic programs of gene expression in the macrophage populations of the mouse and human liver. Results from these studies will inform efforts to target macrophages for therapeutic purposes.